Alaska Environmental Health Laboratory enhancing capacity and capability of food testing to support an integrated food safety system.

ASEHL Project Summary-Overall SFY21
By maintaining and enhancing ISO/IEC 17025 for food testing, the Alaska State
Environmental Health Laboratory (ASEHL) will continue to deliver both scientifically valid
and legally defensible data to its clients. The clients, including the Alaska Food Safety
and Sanitation (FSS) Program and U.S. FDA, will benefit by receiving enhanced
customer service, consistent turnaround times, and little to no down time. Accreditation
allows ASEHL to satisfy Standard 10 of the Manufactured Food Regulatory Program
Standards (MFRPS) as the primary designated testing facility for the Food Safety and
Sanitation Program (FSS). FSS is in full conformance to MRFPS standards.
The following are for consideration to enhance our ISO scope for year 1: STEC/“Big 6” E.
coli, Inorganic Arsenic, and Gamma Radiation Screening to further support our
manufactured food testing program beyond pathogen surveillance to better support the
food regulatory program and manufactured food producers.
ASEHL has had QC programs which produced scientifically valid data for many years.
ISO accreditation and applying ISO across all programs brings all operations, from top
management down and from other State divisions, together in a single direction:
improvement toward total quality management. These fundamental, cultural changes are
essential to ASEHL's ability to continue and excel in its service to the State of Alaska.

Public health relevance
ASEHL Project Narrative-Overall SFY21-25 By maintaining and enhancing ISO/IEC 17025 for food testing, the Alaska State Environmental Health Laboratory (ASEHL) will continue to deliver both scientifically valid and legally defensible data to its clients. The clients, including the Alaska Food Safety and Sanitation (FSS) Program and U.S. FDA, will benefit by receiving enhanced customer service, consistent turnaround times, and little to no down time. Accreditation allows ASEHL to satisfy Standard 10 of the Manufactured Food Regulatory Program Standards (MFRPS) as the primary designated testing facility for the Food Safety and Sanitation Program (FSS). FSS is in full conformance to MRFPS standards.